Pan-neuronal functional imaging and anesthesia

Volatile anesthetics, such as isoflurane, produce all stages of general anesthesia including unconsciousness,
amnesia, analgesia and muscle relaxation. Despite their ubiquity, the fundamental mechanisms of action of
these drugs remains unknown. Elucidating the mechanisms by which clinical anesthesia is produced is the
foundational unanswered research question in the specialty of anesthesiology. The routine use of volatile
anesthetics is not without clinical risk. Multiple exposures to anesthetics in infancy leads to possible behavioral
problems in later life, and persistent post-operative cognitive dysfunction is seen in the elderly after anesthesia.
Historically, research in this field has proceeded along two tracks: either molecular analysis looking for specific
receptors for the volatile anesthetics (an approach that has largely foundered due to diffuse interactions with
many receptors whose effects do not combine appropriately), or the gross measurement of neuronal activity in
entire regions of the brain using EEG and fMRI (which are fundamentally limited by resolution). Clearly, there is
an enormous gap in length resolution between synaptic-scale and EEG-scale. We hypothesized that the onset
of anesthesia, and hence the loss of consciousness, is due to disruption in the communication between
neurons at the level of small neuronal networks that lie well below the resolution limit of EEG and fMRI. We
study the effect of anesthetic agents on intercommunication within intact, living neural networks, with single
neuron resolution. We use C. elegans, the creature with the simplest, most tractable neuronal architecture in
which anesthesia is known to be inducible. Using light-sheet microscopy, a combination of fixed and calcium-
sensitive fluorophores expressed under neuronal promoters, and our customized supercomputing toolchain for
image analysis and signal extraction, we track and capture the activity of essentially the entire nervous system
and examine its behavior under varying levels of anesthetic exposure normalized to comparable levels used in
human surgery. Using two-photon imaging, we are able to perform similar experiments in the mouse and
extract activity from selected regions of the somatosensory cortex in both awake and anesthetized states.
We will use a system of differential expression of fixed neuronal fluorophores in C. elegans to allow the precise
identification of individual neurons under light-sheet imaging. In combination with the C. elegans connectome,
we will determine the neuronal pathways that underlie anesthetized vs conscious states, how anesthetics alter
chemical and electrical synaptic connections to induce these states, the changes in neuronal connectivity that
permit the anesthetized state to resolve back into consciousness, and hence delineate the mechanisms of
clinical post-operative cognitive dysfunction in the old and neurodevelopmental impairment in the young. We
will extend our imaging and analysis techniques into vertebrate zebrafish, building a phylogenetic bridge in the
action of anesthetics from simple creatures to humans. We will demonstrate that these changes in neuronal
activity are consistent with the gross statistical hallmarks of anesthesia seen in the EEG in humans.

Public health relevance
Volatile anesthetics induce all stages of general anesthesia including unconsciousness, amnesia, analgesia and muscle relaxation, but we have no satisfactory answer as to how this occurs physiologically. Using novel fluorescent microscopy in C.elegans, we are now able to image neuronal activity in real-time, in vivo, and at resolutions capable of capturing the activity of individual neurons and entire populations of complex neuronal networks simultaneously. Our experimental system, and its progressive extension into higher-order animals, will allow us to measure the activity of the individual identifiable neurons within large-scale neuronal circuits to understand how subtle modifications in discrete neuronal dynamics lead to the gross but reversible functional defects at the level of the overall nervous system that produce the clinical state of anesthesia in both simple creatures and humans.